DOUBLE BLIND, PLACEBO CONTROLLED TRIAL OF B2036 PEG IN ACROMEGALY

Somavert (B2036), a growth hormone receptor antagonist, therapy in patients with acromegaly will lower IGF-I levels. Recruitment ongoing.